Enhancement of California's Integrated Food Safety and Security System

Proposed Application: Enhancement of California’s Integrated Food Safety and Security System
The Food and Drug Laboratory Branch (FDLB), California Department of Public Health (CDPH) is
submitting the following proposal for FOA# PAR-20-105, under disciplines of Microbiology (A), Chemistry
(B), and discipline D Special Projects. FDLB has been an FDA FERN laboratory since 2008. FDLB has the
capability and capacity to fulfill the goals of the referenced cooperative agreement program in terms of
the experience and expertise of its trained staff, available facilities, established validated equipment,
and its on-going participation in FERN training, surveillance, proficiency testing, and other cooperative
agreement programs activities. FDLB is the primary testing laboratory for State food and drug regulatory
agency which enrolled in California’s Manufactured Food Regulatory Program Standards.
1. Three projects in Chemistry area (PI: Dr. Dadong Xu, [email]):
(1) Discipline B Track 1, Food Defense (150 samples): We are proficient in all three FERN chemistry
methods (CHE.0006, CHE.0008, and EAM 4.7) as well as FDLB-developed methods to carry out the tasks
for this track, with capacity of more than 150 samples; 2) Discipline B Track 2, Human Food Product
Testing (500 samples): We have the capability and capacity to perform human food product testing for a
variety of analytes, such as natural toxins, toxic metals, seafood toxins, and some pesticides. We will be
able to enhance our testing capability in additional analytes including vitamins and drug residues; 3)
Discipline D Special Projects, Track 3, Method Development / Validation in Chemistry: We apply to
participate in all the single and multi-laboratory validations for histamine, arsenic speciation in seafood,
bottled water analysis using ICP-MS, and veterinary drug residues in milk products.
2. Eight Projects in Microbiology area (PI: Dr. David Kiang, [email]):
Discipline A track (1) Food Defense- We have the capacity to analyze all the proposed food and food
products related to microbiological contamination through intentional means and to enhance the
network capacity and readiness of state BLS2+ and BSL3 laboratories; track (2) Human Food Product
Testing- We can improve the food testing surveillance programs through microbiological analysis of
food products and environmental samples; track (3) Animal Food Product Test- We can analyze animal
food products for microbiological contaminants and improve the animal food testing surveillance
program for the state; Track (4) Whole Genome Sequencing; track ( 5) Microbiology Capability/Capacity
development 2020-21; Discipline D Special Projects, track (1) Sample collection for microbiology and
Chemistry; track (2) NFSDX and ORAPP integration; track (3) Method Development/Validation for
microbiology - We will participate in the two multi-lab validations.

Public health relevance
Project Narrative FDA Laboratory Flexible Funding Model (U19) Cooperative Agreement, FOA PAR-20-105 The proposed projects that will be performed within California Department of Public Health, Food and Drug Laboratory Branch will greatly enhance the capacity and capabilities of California's human and animal food testing to support the State integrated food safety system. The application includes multiple tracks under Microbiology, Chemistry, and Special Projects disciplines. These projects, when properly funded, will provide quick emergency response testing and surge capacity in large scale events, produce large amount of data through surveillance activities to find contamination trends and identify emerging issues for food supplies, and expand the methodologies, types of analytes, and food matrices through method development and validation activities.